Regulators of Food Intake

Energy intake and dietary macronutrient composition is the most difficult part of the energy balance equation to measure. In a natural history study of factors which predict food intake and using an inpatient computerized vending machine system, food intake has been measured over 340 individuals. This study has yielded crucial information about ad libitum food intake and generated important new hypotheses to be tested in this field. We are also planning a large outpatient study of the inputs to ad libitum food intake. This will involve collection of multiple inputs including physiologic, behavioral, environmental (including gut microbiome measurements) and genetic with ad libitum intake as measured by a buffet meal as the outcome. This will be a data driven study using machine learning to identify novel pathways and determinants of ad libitum intake.

Understanding the potential confounders of energy intake is vital to this field. We have found that both fat free mass (adjusted for height) and 24-hour energy expenditure are associated with ad libitum food intake. In mediation analysis, energy expenditure accounts for over 80% of the explained variance in energy intake indicating that energy expenditure rather than fat free mass drives energy intake. Thus, increases in metabolic rate (as a weight loss intervention) may have the paradoxical effect of stimulating excess caloric intake. In fact, in further analyses, we have found that energy intake adjusted for energy expenditure predicts weight gain. We were able to quantify how much intake affects the protective effect of EE on weight gain calculating that for every 0.46kg/100 kcal higher EE there is a counterbalance of -23 kg/100 kcal from drive to increased intake. We are investigating this energy sensing link further in a separate protocol investigating how changes in energy expenditure (as induced by fasting and cold exposure) are associated with food intake. We have found that following 24 hours of fasting in our respiratory chamber, individuals whose respiratory quotient and carbohydrate oxidation rates dropped less ate more after fasting. This implies that individuals with less metabolic flexibility to fasting have greater drive to energy intake. For this study, we have reached our interim analysis point in terms of investigating the association of changes in energy expenditure during cold and the association with changes in energy intake. This analysis will determine if further recruitment for this study is needed.

Using this ad libitum vending machine model, we have found that calories from soda intake predicted future weight gain indicating a role for sweetened beverages as contributor to the current obesity epidemic. In work elucidating hormonal associations with ad libitum intake, we found that participants with higher fasting fibroblast growth factor 21 concentrations consume less soda. We also found that higher fasting GLP-1 concentrations were associated with lower carbohydrate and lower intake of high simple sugar/high fat foods indicating a role for GLP-1 in rewards-based food selection. Higher urinary dopamine a potential marker of reward-based food selection was associated with greater drive to eat and increased energy intake. We have also demonstrated that dietary protein has a negative regulatory effect on short term (meal to meal) protein and total calorie intake, but not on daily intake.

To understand behavioral and psychosocial factors, we have also investigated whether socioeconomic status and food insecurity are associated with energy intake. We found that those with higher food insecurity scores, eat more during the ad libitum period. Moreover, individuals with food insecurity have metabolic risk factors for increased energy intake and weight gain namely higher 24h RQ, higher carbohydrate oxidation, lower lipid oxidation rates and lower fasting concentrations of the appetite suppressing hormone, GLP-1. We are developing a study to follow-up on these concepts. We will measure unpredictability and its association with metabolic parameters including glucose tolerance, physical activity and ad libitum food intake.

We have continued investigating novel dietary biomarkers in our study investigating stable isotopes ratios. The study was a multi-factorial design in which dietary pattern varied by meat, soda, and fish content. Plasma (collected every 2 weeks) and hair were analyzed for changes in the stable isotopes C13 and N15.

In both plasma and hair, carbon isotope enrichment was associated with meat and soda intake, but more strongly with meat intake, while nitrogen isotope enrichment was associated with fish intake. Stable isotope ratios in specific amino acids and fatty acids may provide even more specific food signatures. We found that carbon isotope ratio (CIR) in plasma alanine had a high sensitivity and specificity for soda intake, while CIR for leucine demonstrated the same for meat intake. We also found that amino acid nitrogen isotope ratios (NIR) can denote diet patterns. NIR in amino acid leucine denoted fish intake, while NIR in amino acid threonine was lower in meat and fish intake. We have also found specific long chain fatty acid signatures that denote meat intake. The CIR of plasma saturated and mono-unsaturated fatty acids are sensitive and specific measures of dietary meat intake, but not SSB or fish intake. We measured the total fatty acid concentration in each participant as well. Increased relative abundances of plasma odd-chain fatty acids i-15:0, 17:0, and 17:1 was associated with meat intake, and higher relative abundances of plasma EPA and DHA (20:5n-3 and 22:6n-3) were associated with fish. In this study, we also found important changes in metabolism notably that those who consumed fish for 12 weeks increased their 24h energy expenditure while those who consumed soda decreased their 24h energy expenditure indicating a role of diet pattern (or quality) on EE independent of macronutrient composition.

We began a follow-up study investigating how dose of soda intake over a 12-week period affects stable isotope ratios, additional dietary biomarkers (long chain fatty acid profiles, metabolomics), gut microbiome and energy expenditure. We are successfully and actively recruiting for this study.

An understudied component of food intake is regulation of thirst and thirst perception. Our clinical trial comparing water intake and thirst perception in lean versus individuals with obesity following a 24 hour fast without fluid intake and a 3% saline challenge found that adjusted for body size, lean and obese individuals drank the same amount of water following these challenges, but thirst perception in obese was lower as was their copeptin response to both challenges. Leptin may mediate this lower co-peptin response, but we have not found additional evidence that other hormones purportedly involved in water balance (aldosterone, atrial and brain natriuretic peptide or apelin) differ between lean and obese individuals during these tests. We also demonstrated that disinhibition, a measure of overeating in response to various stimuli, is associated with greater perceive thirst in lean individuals but less those in individuals with obesity.

Adherence is also a crucial component of success for diet induced weight loss. We completed a study investigating whether dietary adherence differed in lean versus individuals with obesity on weight maintaining versus calorie reduction diet. We found that there was no difference in adherence of hunger measures between the groups. These results indicate that difficulty with dietary adherence is not characteristic of individuals with obesity nor driven by hunger associated with dieting. However, we did find that overall levels of perceived stress, anhedonia and food insecurity measured prior to t